Viral and Placental Determinants of HIV-1 Subtype C Mother-to-Child Transmission

Viral and Placental Determinants of HIV-1 Subtype C Mother-to-Child Transmission ABSTRACT This proposal aims to comprehensively describe host and virus biology associated with HIV-1 subtype C (HIV-1 C) mother-to-child transmission (MTCT). We hypothesize that HIV-1 C MTCT is mediated by both placental and viral determinants. To address this hypothesis, we will: 1) genotype and phenotype vertically transmitted envelope (env) genes, 2) characterize envelope genes isolated from archived placental biopsies, 3) describe the placental environment during MTCT. All experiments will use previously collected samples from a well-characterized cohort of 744 HIV-1C-infected pregnant Malawian women characterized as nontransmitting (NT), in utero (ID) mother-offspring pairs (MOPs) and intrapartum (IP) MOPs. In a preliminary study, we enumerated HIV-1 C V1/V2 env diversity in 48 MOPs and found that infants had significantly fewer variants than their mothers and confirmed that HIV env diversity is restricted during MTCT in a non-stochastic manner. Specific Aim I tests the hypothesis that this restriction is facilitated by specific env genotypes and it will be accomplished using single-genome amplification to clone full-length envelope genes to: a) compare V1/V2 loop lengths, b) enumerate putative glycosylation sites, c) pseudotype the cloned env genes against CCR5, CxCR4, CD4hi and CD4lo cells. As an independent investigator in the Center for Microbial Interfact Biology at Ohio State, I will focus on IU MTCT and test the hypothesis that the placenta is a unique HIV1-C compartment. Using a heteroduplex tracking assay, I will compare HIV-1C env genes from matched peripheral blood, placental blood, and placental biopsies (Specific Aim 2). Placental specific variants will be characterized using the heteroduplex tracking assays learned during the mentored phase. In Specific Aim 3, placental specific variants will be psuedotyped against primary placental trophoblasts and Hofbauer cells. Finally, in Specific Aim 4, previously collected placental biopsies will be analyzed for HIV-1 C, CCR5, CD4, and CXCR4 expression. The results of this project will provide a comprehensive description of the HIV-1 C envelope genes and the placental environment conducive to HIV-1 subtype C MTCT.